Stress response signaling as a metabolic sensor in reproduction

PROJECT SUMMARY
Reproduction is a systemic decision that relies on nutrient availability to support the high energetic cost
of gamete production and reproductive behaviors. Disorders that correlate with insufficient or excess body fat
mass like anorexia nervosa or polycystic ovarian syndrome are associated with decreased ovulation and infer-
tility. In humans and the model organism Drosophila melanogaster, steroid hormones are essential for reproduc-
tion, though the molecular cues that relay nutrient information to direct hormonal function are not well understood.
In Drosophila, activation of Ecdysone receptor (EcR) by the steroid hormone 20-hydroxyecdysone (20E) is re-
quired for oocyte maturation in the ovary. Interestingly, the transcription factor Cryptocephal (Crc), which is in-
duced by starvation via the Integrated Stress Response (ISR) pathway, interacts physically with EcR. This study
will examine how nutrient sensing alters reproductive capacity via ISR signaling and steroid hormones.
I recently found that loss of crc in the fat body (FB), a liver-like and adipose-rich tissue in Drosophila,
caused follicle death and decreased lipid/yolk protein composition, defects associated with 20E dysregulation.
Additionally, loss of ISR factors caused excess retention of mature oocytes in the ovary. Together, my data
suggest that ISR signaling co-regulates oocyte maturation and egg laying behavior. During the training (K99)
phase of this award, I will uncover how Crc and EcR link metabolic status to gametogenesis and egg-
laying behavior. To this end, I am collaborating with Dr. Kafui Dzirasa at Duke University to adapt a novel neural
editing tool for use in Drosophila, creating artificial synapses to characterize regulation of egg laying by the ISR.
Starvation, which activates the ISR, attenuates post-mating increases in intestinal function and courtship
behavior. During the independent (R00) phase, I will apply the insights and tools acquired during the
training phase to identify molecular cues downstream of ISR signaling that control nervous system and
gut functions to alter reproductive potential. First, I will determine how the ISR regulates female courtship
behavior, which requires inputs from central and peripheral neurons. Next, I will leverage the collaborations
forged during the K99 phase to characterize organism-wide expression of EcR- and Crc-responsive reporters
under different feeding conditions to interrogate the roles of Crc and EcR in the intestine, where both regulate
stem cell dynamics. This will open multiple lines of inquiry into how nutrient sensing controls multiple reproductive
events via ISR signaling and inter-organ crosstalk. My proposed studies will develop novel tools and insights
that will lay a strong foundation for my independent research program, wherein I will characterize diverse phys-
iological consequences of ISR and steroid hormone signaling in metabolic tissues and decipher how this impacts
behavior and whole-organism physiology. Ultimately, my work will reveal important insights into how metabolism
controls reproduction across organisms, which may lead to novel therapeutics for treating human metabolic
disorders that cause sex hormone dysregulation and infertility.

Public health relevance
PROJECT NARRATIVE Many metabolic disorders are associated with infertility and sex hormone dysregulation, though the molecular mechanisms that link nutrient status to reproductive events are not well understood. The evolutionarily conserved Integrated Stress Response (ISR) pathway responds to environmental and cellular stress cues like starvation, directing transcriptional changes that prioritize survival at the temporary expense of nonessential processes like oogenesis and mating. The work proposed herein will combine genetic, biochemical, and neuromodulatory tech- niques to examine how the ISR links nutrient status to reproductive potential via steroid hormones, revealing new insights into how metabolism impacts fertility across organisms.